Dynamic BH3 Profiling with Patient Derived Organoids of Esophageal Cancer and Mesothelioma Enable Precision-Based Targeting of the Mitochondrial Apoptotic Pathway

SUMMARY / ABSTRACT
Esophageal cancer and malignant pleural mesothelioma are difficult to treat because they typically harbor over
3000 somatic mutations from the repeated insults of reflux and asbestos. Identifying one mutation or pathway to
target is circumvented by the tumor cell through new mutations and bypass pathways. For this reason,
targeting the mitochondrial pathways represents a substantially improved approach because they are
downstream of oncogenic driver proteins and pathway mutations.
Recently, we have shown that chronic exposure of pre-neoplastic, Barrett’s esophageal cells to bile salt induced
malignant transformation through a mechanism termed, ‘Minority MOMP (mitochondrial outer membrane
permeabilization)’. MOMP is regulated by the B-cell lymphoma-2 (Bcl-2) family of proteins that are divided into
pro- and anti-apoptotic proteins that interact at Bcl-2 homology-3 (BH3) domains. Minority MOMP partially
activates the intrinsic pathway of the apoptotic machinery to a level not sufficient to result in cell death; rather, it
promotes genomic instability, cellular transformation, and tumorigenesis. We noted that in ‘Minority MOMP’,
Barrett’s cells resisted apoptosis through the upregulation of the anti-apoptotic protein, Mcl-1. When we targeted
Mcl-1, Minority MOMP shifted from the sub-lethal mitochondrial activation to frank apoptosis and tumor cells
died. Dynamic BH3 profiling (DBP) provides an assay to measure which anti-apoptotic proteins are responsible
for the resistance for each tumor. By determining the relevant anti-apoptotic protein, a class of compounds, BH3
mimetics, target those specific protein. Recently, a biochemical ‘toolkit’ utilized DBP to identify the appropriate
BH3 mimetic in murine cells that overexpressed bcl-2 proteins. Patient-derived organoids (PDO) can
recapitulate tumor response to therapy. If a comprehensive biochemical toolkit utilizing DBP in PDOs
identifies proteins that enable resistance directly from patient tumors, then precision-based targeting of
the Bcl-2 proteins provides a therapeutic strategy to overcome treatment-refractory cancers.
Our goal is to disrupt the mitochondrial balance that enables carcinogenesis but blocks apoptosis by directly
targeting the proteins responsible for resistance. We will establish a biochemical toolkit to predict treatment
response in esophageal cancer and mesothelioma by utilizing a DBP-PDO model. Targeting these proteins will
shift Minority MOMP toward apoptosis by blocking the compensatory anti-apoptotic proteins. Our hypothesis is
that the DBP-PDO model is a clinically actionable bioassay within seven days from tumor biopsy. This current
research will allow us to circumvent intractable bypass mechanisms and mutations of cancer cells altogether by
targeting the downstream mitochondrial resistance mechanism. This novel strategy is expected to shift Minority
MOMP toward frank apoptosis and thus render these cells vulnerable to standard therapies.

Public health relevance
NARRATIVE The proposed research is relevant to public health because esophageal cancer and mesothelioma are highly lethal cancers that easily resist treatment through their ability to mutate. Supporting the NCI mission to find more effective strategies for treating cancer, Dynamic BH3 profiling (DBP) uses a tumor biopsy to determine why a cancer cell does not die when treated with chemotherapy. DBP will enable us to disrupt the metabolism of the tumor cell, so that we can destroy it, regardless of its ability to mutate, and extend the lives of the patients with these cancers.